TRD1 - Multimodal Imaging for Spanning Multiple Spatial Scales in the Brain

Project Summary/Abstract
Brain function is mediated by hierarchical local and long-range circuits organized across multiple spatial
scales. Bridging and spanning these scales of organization is essential for understanding brain function and
ultimately dysfunction; however, no single existing technology can accomplish this daunting task. Human brain
activity and connectivity can be studied with non-invasive magnetic resonance (MR) methods that can cover
the entire brain. However, the spatiotemporal resolution and fidelity to neuronal activity is limited because of
the intervening neurovascular coupling that is the source of the MR mapping signals. These limitations can be
overcome if MR resolutions and fidelity can be improved so as to reduce the heterogeneity of the responses
within an MR voxel and, in addition, the MR method is combined with other techniques that simultaneously
report on neuronal and/or neurovascular responses, ideally sampling the activity within one or more MR voxels
at the single neuron, synapse or vessel level. Besides interrogating the link between neuronal activity and the
MR based functional mapping signals, the complementary nature of such a combination of techniques would
provide the means for bridging the multiple spatial and temporal scales, going from the cellular and synaptic
level to coordinated activity over billions of neurons spanning large parts of the brain, if not the entire brain.
This TRD approaches this problem by proposing to develop i) advanced MR methods for imaging brain
function and connectivity at unprecedented spatial resolution using very high magnetic fields, ii) combining
such MR measurements with simultaneous measurements of multi-photon recordings of neural signals (at
single cell and/or synapse level) and corresponding hemodynamic responses at the level of individual
arterioles, capillaries and venules, within the environment of an ultrahigh field (UHF) magnet on the same
animal and under the same experimental conditions. Because of the invasive nature of the optical methods the
combined experiments can only be performed in animal models while the MR techniques to be developed
would be applicable to human imaging as well.